Women’s Social Ties and Psychosocial Well-Being in a Resource-Limited Patriarchal Setting: A Longitudinal Perspective

PROJECT SUMMARY [Original Proposal]
The proposed study will investigate midlife women's relationships and support exchanges with their late-
adolescent and adult children, as well as with other relatives and non-relatives, and the implications of these
relationships and exchanges for women's psychosocial well-being in a rural sub-Saharan setting. The study
will leverage and expand upon a unique panel database consisting of five rounds of survey and qualitative data
collected from rural women between 2006 and 2018 as part of the project Men's Migrations and Women's
Lives in Mozambique. We propose to extend this existing panel by conducting two new waves of survey and
qualitative data collection three years apart. The new data will focus on material, instrumental, and socio-
emotional support exchanges between panel participants and their children, relatives, in-laws, and non-
relatives and on panel participants' life satisfaction, happiness, self-efficacy, depression, anxiety, and related
psychosocial outcomes. The analyses of the dynamics of social interactions and exchanges and of their
consequences for women's psychosocial well-being between the two proposed waves will integrate the
existing panel data on participants' marital and reproductive trajectories, experience of husband's labor
migration, history of co-residence with children and investment in their health and education, as well as
changes in women's physical health and economic conditions, to elicit longer-term processes that shape the
outcomes of interest. The project will be carried out by an experienced bi-national multidisciplinary team with
complementary expertise and a long record of successful research collaboration. The results of the study will
contribute to greater understanding of midlife rural women's health and well-being in rapidly changing
resource-limited patriarchal settings and will inform policies aimed at improving the welfare of this large and
vulnerable population segment.

Public health relevance
PROJECT NARRATIVE [Original Proposal] The proposed study will examine midlife women's relationships and support exchanges with their late adolescent and adult children, as well as with other kin and non-kin, and the implications of these relationships and exchanges for women's psychosocial well-being. The experienced bi-national team will collect and analyze survey and in-depth interview data building upon an existing longitudinal panel of women in rural Mozambique, a setting that in many respects is typical of sub-Saharan Africa. The results of this study will fill important gaps in our understanding of intergenerational and community relationship dynamics and their consequences for women's welfare in rapidly changing resource-limited patriarchal contexts and will inform policies aimed at improving health and well-being of rural women and at optimizing health and social services for that vulnerable population segment.